Targeting immune inhibitory molecule SUSD2 to reverse immunosuppression

Project Summary/Abstract
Sepsis is the most common cause of death in many intensive care units and represents a major burden to the
US health care system. Despite advances in intensive care technology and mechanical ventilator support,
pharmacological options for sepsis are limited, which reflects an insufficient understanding of host-dependent
mechanisms that underlie this pathophysiological disorder. A wealth of evidence from recent clinical and
experimental sepsis studies indicates that a prolonged immunosuppressive status, due to profound cell death
and dysfunction of lymphocytes, is a critical determinant of sepsis-elicited mortality. Therefore, restoration of
lymphocyte cell survival and functions by blocking immune inhibitory molecule(s) may represent a promising
therapeutic regimen for treating sepsis. In this Proposal, we aim to study the role and mechanism of a
previously unrecognized immune inhibitory molecule called SUSD2 (sushi domain containing 2) in promoting
sepsis-induced immunosuppression. Through an unbiased gene profiling assay, our previous study has
identified a cell surface molecule SUSD2 whose high expression correlated with an immunosuppressive
phenotype in an experimental cancer model. In this Proposal, we observed elevated Susd2 expression in T
lymphocytes in experimental septic animals and patients with sepsis compared to non-septic controls. Genetic
deletion of SUSD2 (Susd2−/−) resulted in a significantly improved animal survival and attenuated apoptosis of T
lymphocytes in the cecal ligation and puncture (CLP)-induced polymicrobial sepsis model. Mechanistically, our
preliminary studies discovered an inhibitory effect of SUSD2 on interleukin-2 receptor (IL-2R) signaling, a well-
established pathway essential for T cell survival and effector functions. The goal of the proposal is to examine
the causal effect of SUSD2 on cell death and dysfunction of T lymphocytes in microbial sepsis. We
hypothesize that 1) elevated SUSD2 expression leads to diminished IL-2-dependent cell survival and effector
functions in T lymphocytes, resulting in a sustained immunosuppressive state and worse disease outcome in
sepsis; 2) enhanced activation of STAT5 (signal transducer and activator of transcription 5) and BATF (basic
leucine zipper ATF-like transcription factor) signaling maintains cell survival and effector functions in Susd2−/− T
cells post sepsis; 3) SUSD2 blockade reverses sepsis-induced cell death and dysfunction of T lymphocytes.
Single-cell RNA sequencing analysis of circulatory immune cells will be performed to examine the inhibitory
effect of SUSD2 on T cell response post sepsis at the single-cell level. We will test whether treatment with a
neutralizing anti-SUSD2 antibody reverses dysfunctional T cells isolated from septic patients. Results of these
studies will provide both experimental and clinical evidence to support a promoting function of SUSD2 on
sepsis-induced immunosuppression, which can potentially lead to the development of new approach for sepsis
treatment.

Public health relevance
Project Narrative Sustained immunosuppression due to lymphocyte cell death and dysfunction exacerbates sepsis-induced mortality. Based on my preliminary results, I aim to study the role and mechanism of an immune inhibitory molecule, SUSD2, in promoting T lymphocyte cell death and dysfunction during microbial sepsis. Understanding the function of SUSD2 in sepsis-induced immunosuppression will be instrumental for the generation of new strategy targeting the prevention and/or treatment of this complex syndrome.